Eliminating Ventricular Tachycardia: Pivotal Clinical Trial using the Durablate® Catheter

Ventricular tachycardia (VT) causes more than half of the 170,000–450,000 sudden cardiac
deaths (SCD) that occur annually in the United States. Implantable cardioverter defibrillators
(ICDs) are the standard of care, but they are expensive (the total cost of an ICD implant
exceeds $50,000) and not curative. Patients who receive ICDs are subject to shocks to halt
episodes of VT, and those shocks can be painful and traumatic. RF ablation represents a
potential method for curing VT, at a much lower cost than ICDs, but while RF ablation has been
successful at treating atrial arrhythmias, it is not as effective at treating VT. An ablation tool
capable of treating VT has the potential to improve ICD therapy by eliminating shocks or even
the need for ICD implants, greatly reducing the cost to the health care system of treating VT
while also improving the lives of patients affected by VT. Recent advances in 3-D
reconstruction of CT or MRI images and with merging those images with electroanatomic maps
have made identification of the tissue that needs to be ablated easier. We have developed the
ablation tool that can reliably treat all VT foci.
We have developed the Durablate® Catheter and SERF ablation specifically the treatment of
VT. Our technology delivers heated saline along with RF energy and is unique in its ability to
treat the large volumes of cardiac tissue necessary to eliminate arrhythmogenic tissue located
either on the endocardial surface or deep in the ventricular wall. Our technology can treat much
larger volumes of tissue than conventional RF because saline carries the heat generated by RF
into tissue by convection. We also have fine control over the size of the ablated lesion since we
have control over the amount of saline delivered. SERF lesions can be as small or as large as
the physician needs and they will be the size the physician calls for.
We have successfully concluded a small first-in-human study whose results were recently
published in Circulation: Arrhythmia and Electrophysiology. An accompanying editorial
described the results as “impressive” in a patient population with “clinical characteristics that
would intimidate even the most optimistic and experienced VT ablation enthusiasts.” The FDA
has awarded our technology Breakthrough Device Designation and has approved our IDE for
our pivotal clinical trial.
We will conduct the 154-patient single-arm study at seven centers. Patients will be eligible for
the study if they have recurrent, symptomatic VT; if they have failed prior cardiac catheter VT
ablation; if the etiology of the arrhythmia is related to structural heart disease; or if a target
arrhythmia has been treated by an implanted ICD. Successful completion of this clinical trial will
result in the US clearance for the Durablate catheter and will offer an underserved patient
population a better quality of life and the possibility of a cure.

Public health relevance
Thermedical is developing the Durablate® Catheter which will deliver Saline Enhanced RF (SERF) ablation to treat Ventricular Tachycardia (VT), a condition that in the United States kills more than half of the 450,000 people who die from Sudden Cardiac Death each year. Currently, VT is treated with Implantable Cardioverter Defibrillators (ICDs), expensive devices that halt VT by delivering shocks to the patient. These shocks can be painful, and recent studies indicate that they also contribute to a shortened life expectancy. A recent first in human clinical trial showed that the Durablate can eliminate or substantially reduce the number of shocks that refractory patients are receiving from their ICDs. Thermedical’s ablation technology will improve the quality of life for patients who have VT and possibly extending their life. Long-term the Durablate Catheter may be used for primary prevention of VT which will greatly reduce the cost of VT treatment and improve the lives of patients suffering from VT.